Improving prosthetic provision in rural communities: limb scanning with caregiver assistance

PROJECT SUMMARY (PUBLIC ABSTRACT)
When the prosthetic socket of a Veteran with a lower limb amputation no longer fits or is damaged beyond repair,
a new prosthetic socket is warranted. The provision of a new socket requires multiple clinical visits which can
place a high travel burden and potential pandemic exposure stress on Veterans who live in rural communities
far from VA Medical Centers or alternative prosthetic clinics. This research seeks to determine if one of the in-
person visits traditionally needed to obtain a well-fitting prosthesis can be performed remotely with the assistance
of a helper. We seek to discover if an untrained individual (a helper) can wield inexpensive, easy to use, digital
technology to capture the shape of a residual limb to see if it can be used to fabricate a prosthetic socket that
fits at least as well as one fabricated by a prosthetist using traditional, hand casting methods in the clinic.
The expected result of this research is an evidence-based prosthetic fabrication process that reduces Veteran
travel burden while providing a prosthesis that fits at least as well as the current standard-of-care. The upshot is
a clear improvement in prosthetic provision for Veterans, particularly for those who live in rural communities.
To make this determination, we propose to perform a between-subject experiment with two specific aims. To
determine differences in goodness of fit between the two study sockets, we will use both patient reported
outcomes, and the pressure applied to the distal end of the residual limb.
Specific Aim 1: Determine if patient reported outcomes, by subjects wearing a prosthetic socket whose shape
was captured with study helper assistance, are at least as good as those reported by subjects wearing a socket
whose shape was captured by a prosthetist. We propose to recruit Veterans with a below knee amputation and
their study helpers to participate in a human subject experiment. Participants will be randomly assigned and fit
with either a prosthesis made with study helper assistance and digital methods, or one made wholly by a
prosthetist using traditional methods. Patient reported outcome metrics will be collected while the subject is still
wearing their as-prescribed socket at the beginning of the study (baseline), and again after wearing the study
prosthesis for two weeks.
Specific Aim 2: Determine if distal end residual limb pressure, measured from a group of individuals fit with a
prosthetic socket whose shape was captured with study helper assistance using digital methods, are no worse
than those measured from a group of individuals fit with a prosthetic socket whose shape was captured by a
prosthetist using traditional methods. Concurrent with the human subject procedures briefly described above,
we propose to fabricate duplicates (copies) of the two prosthetic sockets used by each subject in Specific Aim
1. A novel sensor will be embedded in these duplicate sockets which can measure the pressure applied to the
distal end of the residual limb. Measurements of distal end residual limb pressure while standing and walking
for both the as-prescribed and study sockets will be collected at the beginning of the study (baseline), and again
after two weeks.
The data from our experiments will be used to determine if residual limb shape capture by a helper using digital
technologies can be used to make prosthetic sockets that fit at least as well as those made by a prosthetist using
traditional, hand casting techniques.
One third of all Veterans live in rural communities far from VA Medical Centers. When Veterans with a lower limb
amputation need a new prosthetic socket, attending in-person clinical visits can be a challenge. If our hypotheses
are supported, this research will provide evidence to support the use of digital technology as part of clinical
practice, enabling a remote, study helper enabled alternative to one of the in-person clinical visits needed to
fabricate a well-fitting prosthesis.

Public health relevance
PROJECT NARRATIVE (RELEVANCE TO VETERANS) An estimated 1500+ Veterans experience a lower limb amputation each year at VA Medical Centers, a third of whom will receive their first prosthesis within one year from their surgery [1]. About a quarter of all Veterans live in rural communities far from VA Medical Centers [2]. When they need a new or replacement prosthesis, multiple clinical visits are required. Eliminating one of these visits by remotely capturing the Veteran’s residual limb shape, with the assistance of a caregiver or helper, has the potential to improve their access to care. This research will provide evidence to determine if prosthetic sockets, made in part with remote study helper assistance, fit at least as well as prosthetic sockets made entirely with in-person prosthetic services. The standard is a well-fitting prosthesis. Our goal is to determine if advances in technology can meet this standard while improving access and service delivery.